The Function of Small RNA-Based viral Defense System in E. coli - Renewal 1

CRISPR-Cas (Clustered Regularly Interspaced Short Palindromic Repeats-CRISPR-associated genes)
loci are present in almost all archaea and half of eubacteria. They protect prokaryotes from foreign
genetic elements. While highly diverse, all CRISPR-Cas systems function through three common steps:
1) adaptation, i.e., acquisition of short foreign DNA sequences (spacers) into CRISPR arrays; 2)
production of mature protective CRISPR RNAs (crRNAs), and 3) interference, when Cas nucleases
guided by crRNAs destroy nucleic acids containing complementary targets. Studies of the interference
part of CRISPR response have revolutionized the field of genomic editing. The less-studied adaptation
part limits global horizontal gene transfer and can be harnessed for creation of DNA-based recording
devices and control of the spread of antibiotic resistance genes. Initial CRISPR immunity is built in the
course of “naïve”, non-discriminate acquisition of short intracellular DNA molecules – prespacers - as
spacers into CRISPR arrays. It occurs very infrequently and can lead to suicidal self-interference. A
remarkable mechanism called “priming” operates in type I CRISPR-Cas systems: acquisition of spacers
from DNA with sequences matching pre-existing spacers is dramatically stimulated compared to naïve
acquisition from DNA devoid of such sequences. Primed adaptation is highly beneficial to the host: it
rapidly leads to specific acquisition of additional interference-proficient spacers from genetic parasites
and ensures that no self-targeting spacers are selected. The mechanistic relationship between
interference and adaptation during priming is not fully clear. The goal of this proposal is to dissect
interrelationships between interference and adaptation during priming and to identify cellular processes
that feed the adaptation machinery during naïve and primed adaptation. We will use FragSeq - an
innovative high-throughput approach that identifies short intracellular DNA fragments and that was
developed during the previous funding period - to determine the structure of prespacers and of other in
vivo adaptation intermediates generated during naïve and primed adaptation in diverse CRISPR-Cas
systems classes and types, and identify non-Cas cellular proteins essential for prespacer generation and
spacer acquisition. The understanding of CRISPR adaptation that will result from our work will allow us
and others to optimize the efficiency of the adaptation process, facilitating construction of strains with
desired spacer content/immunity profiles and, by revealing processes that limit adaptation, may help
control viability of bacterial populations by inducing adaptation from cell’s own DNA and self-interference.

Public health relevance
Bacteria acquire immunity to their viruses by capturing viral DNA fragments, storing them in their own genomes, and then using these “memories” to recognize the invaders during subsequent infections and destroy them. We propose to study the molecular details of “CRISPR adaptation” - the poorly understood process by which fragments of foreign DNA become part of bacterial genome.